Mechanisms of vitamin A-dependent risk for tuberculosis progression and prevention

Project Summary
Mycobacterium tuberculosis, the causative agent of Tuberculosis (TB), is the leading cause of human mortality
due to an infectious disease, outside of the COVID-19 pandemic. The limited knowledge on risk factors and
comorbidities for TB progression and the mechanisms by which these promote susceptibility limits the ability to
develop new prevention and treatment approaches. Recently, we published data showing a causal relationship
between vitamin A deficiency and progression to clinical active TB disease, carrying up to a 10-fold higher risk
for human TB progression. The substantial TB risk associated with vitamin A deficiency highlights the need to
understand the mechanisms by which this molecule contributes to TB pathogenesis, particularly in the context
of malnutrition among TB-affected communities, which are often the same communities affected by vitamin A
deficiency. Vitamin A has been shown to have an impact on both innate and cell-mediated immunity, where
diverse roles in immunity convolute the potential contributions of this molecule to TB immunity. We hypothesize
that vitamin A is required for effective cell-mediated immunity to control infection after exposure, and respond
properly to vaccination, requiring production within the lung for development of effective immunity. The goals of
this research are to better understand the contribution of vitamin A bioavailability to the development of the
immune response, the metabolic perturbations of vitamin A during infection that may limit bioavailability, and
how vitamin A status impacts efficacies of BCG vaccination practices. These goals will be achieved through
three Aims using a guinea pig model of vitamin A deficiency developed in our laboratory. We will first determine
the contribution of vitamin A bioavailability to the development of the coordinated granuloma immune response
using single cell and spatial transcriptomic approaches on infected guinea pig lung tissues. Next, we will evaluate
cellular, organ-level, and systemic vitamin A metabolic patterns during infection using stable heavy isotope
tracing methods in the guinea pig model throughout the course of infection. Finally, the impact of vitamin A on
protective efficacy of BCG vaccination, the only vaccine available for TB, will be assessed under conditions of
physiologic and pathologic neonatal vitamin A deficiencies. Upon completing these experiments, we will have
determined the role of vitamin A in the development of the granuloma and cell mediated immunity, the
requirements for, and availability of, vitamin A at the site of infection in the lung, and the impact of existing and
proposed human vitamin A supplementation programs on the efficacy of BCG vaccination. These results will
elucidate mechanisms of TB disease progression, identify the role of vitamin A in TB immunity and propose
informed options for preventive or therapeutic intervention on vitamin A deficiency.

Public health relevance
Project Narrative Vitamin A deficiency is a widespread problem in low-income countries and recently has been identified as a strong risk factor for developing clinical tuberculosis disease. This research aims to better understand the mechanisms by which a lack of vitamin A influences the ability of immune cells to respond to infection, and consequently, the outcome of tuberculosis disease. The goal will be to identify points in which vitamin A deficiency contributes to a more severe tuberculosis outcome in order to inform supplementation and host- directed therapies.